Michigan Embedded LHS Scientist Training and Research (MEL-STaR) Center

Abstract/Summary
The University of Michigan (U-M) Department of Learning Health Sciences (DLHS) proposes to establish an
embedded Learning Health System scientist training and research (“MEL-STaR”) center to support the didactic
and experiential training of embedded learning health system scientists focused on principles of patient
centeredness to improve patient outcomes and experience, health system operations, quality, and health
equity. MEL-STaR Scholars will be embedded in settings (“labs”) where LHS activity is ongoing. These labs
include U-M departments, statewide Collaborative Quality Initiatives, VA centers for quality improvement,
networks of federally qualified health centers, and the PaTH network of PCORnet. DLHS’ multi-disciplinary MS
and PhD program in Health Infrastructures and Learning Systems (HILS), started in 2016, is predicated on the
AHRQ LHS competencies, and remains the only predoctoral LHS-focused degree program in the US. HILS
trainees (40 currently enrolled and 25 graduates) blend coursework in informatics, implementation science,
analytics, and health policy and ethics with an embedded, ‘real-world’ practicum spanning a wide range of
health problems and domains related to LHS. An online HILS MS program was launched in 2021. The
proposed MEL-STaR center is structured around three cores: Administrative, Research and Education (REC),
and Research and Data Analysis (RDAC). The Administrative Core will carry out management, coordination,
and communication functions of the center. A Patient Engagement and Health Equity Catalyst (PEHEC) will be
embedded in the Administrative Core to ensure all aspects of the center include authentic, ongoing stakeholder
engagement, patient-centeredness, and an intentional focus on advancing health equity. The Catalyst will work
with all cores and labs to shape how scholars are selected, trained, what research they focus on, and the
methods they use to optimize both patient-centeredness and health equity in their training and ultimately in
their research careers. Similarly, a Program Evaluation Unit will also be embedded in the Administrative Core
to design and conduct evaluation with clear impact metrics linked to improvements in health system
performance and patient centered outcomes. The REC will support designated “MEL-STaR Scholars” in
didactic and experiential embedded experiences, enabling them to function professionally as LHS scientists
who will transform health systems in ways necessary to improve health and healthcare. The RDAC will provide
resources to enrich the embedded experiences of the MEL-STaR Scholars and a broader range of LHS-related
research activities through advanced resources that reflect the expertise and achievements of U-M faculty.
The three integrated cores--built on nine years of DLHS activity as an academic department, seven years of
operation of the HILS degree program grounded in the AHRQ competencies, and the robust activities of the
“labs” as homes to embedded experiences--will achieve the goals of the MEL-STaR center program at the
highest level.

Public health relevance
Project Narrative The University of Michigan (U-M) Department of Learning Health Sciences (DLHS) proposes to establish an embedded Learning Health System (LHS) scientist training and research (“MEL-STaR”) center to support the experiential training of embedded learning health system scientists. Future LHS scientists will focus on principles of patient centeredness to improve patient outcomes and experience, health system operations, quality, and health equity as they prepare for careers through embedded experiences in settings where LHS activity is ongoing such as within U-M departments, statewide Collaborative Quality Initiatives, VA centers for quality improvement, networks of federally qualified health centers and community mental health centers, and national research networks (e.g. PCORnet).